Advancing the Science and Practice of Ecological Momentary Assessment

Abstract
The proposed research will examine the accuracy of people’s recall of emotional states
and specific events over the course of a 2-hour period. Unlike prior studies of recall over
periods of this length, the current design is experimental in that participants will be presented
with pre-specified patterns of stimuli allowing us to determine how various characteristics of
the temporal presentation (placement of stimuli in the period and intensity of stimuli) affect
recall. A series of studies are proposed that include extensive development of the experimental
stimuli and pretesting of a computer-administered protocol. Techniques to construct questions
that improve recall will also be developed. A final, remote-administration study of 1,000
participants will provide the data for analyses. We expect the results to be applicable to the
coverage model of Ecological Momentary Assessment and similar assessment modalities.

Public health relevance
Narrative Little is known about the accuracy of recall of emotions and events over a 2-hour period, which is relevant for real-world, momentary data collection techniques. This research employs an experimental design to determine if recall is affected by the temporal patterning and intensity of emotions and events, which will inform the use of momentary data collection.